BLOOM: Boosting Language Outcomes of Minimally Verbal Children with ASD

PROJECT ABSTRACT
A major gap in our knowledge is how best to intervene with children with autism spectrum disorder (ASD) who
are progressing slowly in their speech production. By age 4, children who still only have a few functional words
are very likely to remain minimally verbal by school age at 6-7 years. Currently nearly 30% of children with ASD
are classified as minimally verbal (fewer than 20 functional words), and nearly 50% continue to have significant
lags in their speech development1. Several factors likely play a role in speech delays including prelinguistic
social communication skills (e.g., joint attention) and oral motor impairment 7,20,21. Social- communication skills,
especially joint attention and requesting skills, are delayed in children with ASD, and have been linked to their
later language development3,4. The JASPER (Joint Attention, Symbolic Play, Engagement & Regulation)
intervention targets these skills specifically, and has shown improvement in joint attention, and later
language8,11. However, for children with minimal speech skills at age 4, improving social-communication skills
alone may not be enough to improve speech outcomes. An alternative and promising intervention focuses on
the oral motor-sound system with direct prompting of speech. This intervention, PROMPT (Prompts for
Restructuring Oral Muscular Phonetic Targets) is a multidimensional oral-motor approach to speech
production disorders10. This intervention in combination with JASPER may have greater effect on speech
outcomes than JASPER alone for 4 and 5 year- old children with ASD and minimal language production. Thus,
the overarching goal of the proposed project is to determine whether there is additional benefit of adding an
oral-motor intervention (PROMPT) to an evidence-based early intervention (JASPER) for speech outcomes.
Specifically, the primary aim tests whether the combined intervention (JASPER + PROMPT) results in greater
social communicative utterances (SCU) (primary outcome) than JASPER alone. SCUs are unprompted,
generative (non-scripted) verbal utterances that are directed to a social partner for the purpose of sharing
information (comment) or making a request. Secondary outcomes include intelligibility and number of novel
words. Secondary aims focus on longitudinal outcome at kindergarten age, and which children might benefit the
most from this novel intervention, including those with more joint attention or better oral motor development.
Exploratory aims concern electrophysiological biomarkers of change with intervention and whether genetics
play a role as a biological moderator of the effects of treatment. Child participants include 80 4-6 year-olds with
ASD and limited language (<20 functional words). Children are randomized to JASPER or
JASPER+PROMPT for a twice weekly intervention for 12 weeks, with 12 week follow up, and again one -
year later. This study has the potential to dramatically improve communication outcomes for children with
ASD, and addresses a high priority need of the Interagency Autism Coordinating Council and NIDCD.

Public health relevance
PROJECT NARRATIVE This research study, Boosting Language Outcomes of Minimally Verbal Children with ASD (BLOOM), is designed to maximize language outcomes for children experiencing significant language delays, thereby lowering the risk of being classified as “minimally verbal” at age 6. The study empirically develops a randomized, two arm, 12- weeks active intervention approach to determine whether there is additional benefit of adding an oral-motor intervention (PROMPT) to an evidence-based early intervention (JASPER) for speech outcomes (primary: socially communicative utterances; secondary: intelligibility, number of distinct word root, and word combination at age 6). This study has the potential to dramatically improve communication outcomes for children with ASD, and addresses a high priority need of the Interagency Autism Coordinating Council and NIH.